Neuroimaging the impact of respiration and respiratory-gated neuromodulation on human glymphatic physiology

Project summary:
The flow of cerebrospinal fluid (CSF) through the brain is essential for maintaining brain health, and
clears metabolic waste products through the glymphatic system. Disruption of this clearance process is
associated with multiple neurodegenerative disorders, notably Alzheimer’s disease. Two key mechanisms
underlying CSF flow in humans are the respiratory cycle, and coherent neural activity. This project aims to
determine whether synergistic drive of respiration and neural activity enhances CSF flow in the human brain.
We will test how spontaneous respiration is associated with CSF flow and test whether slower breathing drives
higher flow. We will then use respiratory-gated transcutaneous vagal nerve stimulation, a noninvasive
neuromodulation technique to stimulate neural activity, integrating both respiratory and neural activity to
optimally drive CSF flow. Finally, we will test how respiration and respiratory-gated neurostimulation modulate
flow both in the large ventricles, and in the tiny perivascular spaces that are essential for brain clearance, using
a new fMRI-based imaging technique with high temporal resolution to measure rhythmic dynamics in
perivascular flow. Together, these studies will establish how modulation of respiration and neural activity in
concert drives CSF flow through the brain. This work will provide the foundation for future clinical investigations
testing whether noninvasive stimulation integrating neural and respiratory rhythms can improve clinical
outcomes and protect against development of neurological disorders such as Alzheimer’s disease.

Public health relevance
Project Narrative: Cerebrospinal fluid flow is critical for maintaining brain health and clearing metabolic waste products from the brain. Both respiration and neural activity are thought to play a role in driving CSF flow. This project will test the role of both respiratory and noninvasive neurostimulation interventions in regulating CSF flow, laying the foundation for future clinical studies seeking to test therapeutic impact of altering CSF flow in clinical populations.